HEALTH PROMOTION IMMUNIZATION PROJECT

Evaluation of the Health Promotion Immunization Project which established the policy of routine administration of adult immunizations to emergency departments, internal medicine and family medicine patients 65 years or older.